Mechanisms of mutanthuntingtin aggregate engulfment and spreading by phagocytic glia

PROJECT SUMMARY
Neurodegenerative diseases are characterized by the progressive appearance of insoluble inclusions that arise
due to protein misfolding in the brain. Much research has focused on determining mechanisms by which these
protein lesions cause dysfunction and loss of neurons and glia. Accumulating evidence supports the hypothesis
that protein assemblies associated with most neurodegenerative diseases propagate in the brain by templating
the aggregation of properly-folded versions of the same protein, similarly to infectious prions. However, it is still
not well understood how “prion-like” aggregates spread between different cell types in the brain or the relevance
of this to neuropathogenesis. The long-term goal of our research is to identify mechanisms underlying protein
aggregate-induced toxicity and spreading between neurons and glia in the degenerating brain. The overall
objective of this project is to determine normal and pathological functions of phagocytic glia in response to
formation of mutant huntingtin (mHTT) aggregates in neurons. Prior research showing that glial responses to
neural injury shift from beneficial to harmful over time, and emerging evidence that phagocytic glia participate in
aggregate clearance and spreading provide rationale for the current project. The central hypothesis is that
incomplete clearance of engulfed neuronal mHTT aggregates by phagocytic glia promotes formation and growth
of a reservoir of seeding-competent, prion-like species in the brain. This hypothesis was formulated based on
findings that glia mediate prion-like transfer of mHTT, tau, and a-synuclein aggregates, and that phagocytic
clearance of engulfed debris becomes less effective with age and in the disease state. Our recent work indicates
that prion-like transfer of mHTT aggregates between synaptically-connected neurons requires Draper-dependent
phagocytosis, an evolutionarily-conserved glial pathway for clearing debris in the brain. The central hypothesis
will be tested in three Specific Aims, carried out in complementary in vivo Drosophila and in vitro mammalian cell
culture models. In Aim 1, effects of neuronal mHTT aggregates on glial responses to neural injury will be
measured in adult fly brains to gain insight into whether mHTT aggregate engulfment leads to glial dysfunction.
In Aim 2, RNAi-based forward genetic screens will identify modifiers of prion-like spreading of engulfed neuronal
mHTT aggregates to the glial cytoplasm. In Aim 3, roles of the mammalian Draper homolog MEGF10 in mHTT
aggregate transfer between co-cultured neuronal and astrocytic cells will be determined. These studies will
identify novel mechanisms about the basic biology underlying phagocytosis, and disease-related mechanisms
that drive protein aggregate-induced neurodegeneration in multiple cell types. The proposed research is
significant because it addresses critical questions of how phagocytic glia interact with neurons to drive
pathogenesis in potentially many neurological disorders. Our findings will reveal new information about
aggregate-related pathogenesis underlying neurodegeneration and have great potential to identify targets for
novel therapies that treat the underlying cause of these fatal disorders.

Public health relevance
PROJECT NARRATIVE Age-related neurodegenerative diseases have become a major public health concern as their incidence increases in the absence of available cures. This project will examine how a key pathological feature of most neurodegenerative diseases—protein aggregates—contribute to defects in neurons and non-neuronal cells in the brain using a combination of in vivo fruit fly and mammalian cell culture models of Huntington’s disease (HD). Results of this work will expand our understanding of the cellular and molecular mechanisms that underlie HD and related disorders, with the goal of identifying more effective therapeutic targets for neurodegeneration.